Discovery and Application of New Halogenases

Project Summary
The rapid and modular generation of molecular diversity is key to the search for new chemical
functions. One particularly useful functional group is the halogen (X = Cl, Br, I), which enables many
selective and effective downstream strategies for creating structural complexity. In this regard, halogenase
enzymes have provided an important and complementary approach to synthetic catalysts for regio- and
stereoselective introduction of a halogen substituent on a complex scaffold. While many families of
halogenases exist, the radical halogenases provide the greatest potential for reaction diversity, as they are
competent to replace unactivated C-H bonds with a halogen unlike those that operate by electrophilic or
nucleophilic mechanisms. However, the substrate scope of these enzymes has been limited to date to either
protein-bound substrates or large late-stage natural product intermediates. Our group has discovered a new
clade of radical halogenases capable of reacting with small molecule substrates. We now seek to take
advantage of this discovery to develop new tools for in vitro and in vivo synthesis. Specific aims of this
proposal include: (i) elucidating the structure and mechanism of these new radical halogenases, which will
provide important insight into their engineering, (ii) investigating and engineering selectivity in
halogenases.

Public health relevance
Research Strategy 1. Project Summary Discovery and application of new halogenases (R01GM134271): The rapid and modular generation of molecular diversity is key to the search for new chemical functions. One particularly useful functional group is the halogen (X = Cl, Br, I), which enables many selective and effective downstream strategies for creating structural complexity. In this regard, halogenase enzymes have provided an important and complementary approach to synthetic catalysts for regio- and stereoselective introduction of a halogen substituent on a complex scaffold. While many families of halogenases exist, the radical halogenases provide the greatest potential for reaction diversity, as they are competent to replace unactivated C-H bonds with a halogen unlike those that operate by electrophilic or nucleophilic mechanisms. However, the substrate scope of these enzymes has been limited to date to either protein-bound substrates or large late-stage natural product intermediates. Our group has discovered a new clade of radical halogenases capable of reacting with small molecule substrates. We now seek to take advantage of this discovery to develop new tools for in vitro and in vivo synthesis. Specific aims of this proposal include: (i) elucidating the structure and mechanism of these new radical halogenases, which will provide important insight into their engineering, (ii) investigating and engineering selectivity in halogenases. 2. Scientific Justification We are requesting funding for a new High-Performance Liquid Chromatography (HPLC) system in order to replace a broken Agilent HPLC using for purification and isolation of small molecule enzyme products. We have been using an existing HPLC in the laboratory to scale-up purification of products but the instrument is now non-functional. We require this instrument for the isolation of compounds to characterize the regioselectivity and stereoselectivity of the modifications taking place. Our progress on this project has been slow since 2022, when the instrument has not been able to be used. Given that regioselectivity and stereoselectivity is essential to understanding both the mechanism and results of protein engineering studies, this instrument is essential to our studies. A new HPLC system is essential to make progress on several aspects of Specific Aim 2 and Specific Aim 3 of our project. We proposed to explore the mechanism of regioselectivity of halogenases using libraries of mutants. Although these enzyme are screened using a fluorescent screen as well as by LC-MS/MS, we ultimately also need to isolate the products to characterize the regioselectivity and stereoselectivity of the modifications. Because the stereochemistry of these amino acids can be difficult to assess since the modifications take place typically at methylene groups that are distant from the alpha- carbon stereocenter, we often require large amounts of samples. These products often need to be further modified by cyclization or chiral auxiliaries because the methylene chain is insufficiently constrained to relay stereochemical relationships derived from the alpha-carbon stereocenter so that absolute or relative stereochemistry can be assigned. In Specific Aim 3, we have also been examining chemistry downstream of halogenation. These also require isolation of products and full characterization that cannot be provided simply by LC-MS/MS. Given the amounts needed for NMR analysis, we require a functioning and dedicated semi-preparative HPLC. Thus, it will not be feasible to purify this many variants without an HPLC system capable of separation of semi-preparative levels of material (5-20 mg). Given the number and quantity of protein variants to analyze, it is essential to have a dedicated and functional HPLC system to isolate their products for characterization. We have utilized a low flow-rate HPLC (<5 mL/min for semi-preparative columns) and this formed an essential part of our experimental repertoire. However, this was purchased when I first started as an assistant professor at UC Berkeley in 2007 and has now reached the typical end-of-life this type of instrument. The need for the instrument was not anticipated in the original proposal since we had accessed became irreversibly damaged during the course of the project. In addition, we have found that even when operational, the low flow rates caused each run to take 3-4 hours rather than 30-45 min. Given the multiple injections needed for the scale of compound needed, this causes product isolation and characterization to be limiting. We therefore request to purchase a Waters semi-preparative chromatography system with an autosampler, UV-visible detector, and fraction collector. This system would allow us to streamline our characterization process greatly. 3. Training and Maintenance Our group is heavily invested in analytical chemistry, which is a key mode of data generation for this project. As such, we have a robust training process in place where major pieces of equipment (LC-QTOF, HPLC, FPLC) are assigned to both a senior student and junior trainee so that we do not have a break in continuity of care or significant information loss as senior members graduate or move on. They are chosen based on their use of and reliance on the particular instrument. In the case of the HPLC, the lab members in charge of this instrument work on the project above. This senior/junior student pair is then responsible for the general upkeep and maintenance activities for the HPLC. In addition to tracking instrument performance, instrument calibration and cleaning, they are responsible for notifying the laboratory of any major issues and contacting the service team for either questions on troubleshooting small problems or scheduling a service call for preventative maintenance/potentially larger problems. Students in charge of the HPLC have typically been separated by 2- 3 years in their training timeline in order to allow for adequate training of the junior student on the instrument before they 1 transition to the senior position. This particular instrument failed because of issues with the autosampler and fraction collector and not the pumps themselves, which are well maintained by the group. 4. Timeline Since we already have all the columns and accessories necessary to use the instrument, we would expect the HPLC system to be delivered and installed for use within 7 weeks of order placement. 2